Biophysical modeling of inward and outward membrane curvature generation

Project Summary/Abstract: Biophysical modeling of membrane curvature generation for inward and outward
budding.
Curvature generation of cellular membranes is important for communication between the intracellular and extracellular
space. During endocytosis, cells curve their plasma membrane inward to take up cargo from the extracellular space. In
contrast, during the formation of extracellular vesicles, the plasma membrane curves outwards. Both of these processes
are fundamental to cellular function and defects in these processes are implicated in cancer, altered neurotransmission,
inflammation, and heart disease. While many distinct proteins are involved in membrane curvature generation, they
ultimately work together to generate mechanical stress at membrane surfaces. As a result, biophysical modeling has
become an important tool for understanding how curvature may be generated. These models often treat the membrane
as a thin lipid bilayer without detailed considerations of the interactions of the membrane with the environment. As a
result, many of these models ignore the fundamental aspects of curvature generation: the lipid and protein compo-
sition of the membrane, interaction of the membrane with the actin cortex, and interaction of the membrane with key
components of the extracellular matrix including the glycocalyx.
Research in my group in the past 5 years has made fundamental advances in our understanding of the biophysics of
membrane curvature generation that support the hypothesis that interaction of the lipid bilayer with the cytoskele-
ton and the glycocalyx generate differential stresses across the membrane, which ultimately controls the direc-
tion of membrane bending. The magnitude of these stresses depends on the specific biochemical properties of the
molecules involved. Specifically, in endocytosis, we showed that membrane composition can alter membrane tension
and therefore the energy required for endocytosis. Furthermore, we showed that the organization of the cytoskeleton
and linker molecules along the endocytic pit is a critical determinant of force generation during endocytosis. We also
showed that detachment of the membrane from actin cortex is a critical determinant of effective outward budding for
extracellular vesicle formation.
These findings lead us to the following urgent questions about how cellular membranes might generate curvature for
endocytosis and extracellular vesicle formation: First, how does the asymmetry due to lipid and protein composition
determine the direction of membrane budding? Second, how does the interaction with the actin cytoskeleton drive
membrane bending for endocytosis and extracellular vesicle formation? And finally, what role does the glycocalyx play
in altering the direction of membrane bending? Building on our recent discoveries, we aim to answer these questions
using computational modeling to generate experimentally verifiable predictions. These predictions will be tested by
experiments conducted in the Stachowiak, Wehman, and Drubin labs. By incorporating the mechanistic details of the
composition of the plasma membrane, glycocalyx, and the actin cytoskeleton, the quantitative modeling framework we
propose to develop will be applicable to wide range of cellular phenomena.

Public health relevance
Project Narrative The proposed research is relevant to public health because defects in endocytosis and extracellu- lar vesicle formation play important roles in pathological conditions including inflammation, cancer, neurodegeneration, and heart disease. Therefore, the proposed research plan to elucidate the fundamental biophysical principles underly- ing inward and outward membrane curvature generation is relevant to the part of NIH’s mission that seeks to develop fundamental knowledge that will mitigate the burden of human disease. Further, the proposed work will develop in- novative computational models that will allow for potential design and rapid testing of new strategies to treat multiple pathologies and the development of nanotherapeutics.